Spatiotemporal regulation of collective cell behaviors in Drosophila

Normal tissue development and tumor metastasis require extensive cell movements, and border cell
migration in the Drosophila ovary provides a powerful in vivo model. Border cells migrate as a group of two
different cell types, a pair of non-migratory polar cells in the center that recruit 6-8 epithelial cells to surround
and carry them between nurse cells to the developing oocyte, in a structure called an egg chamber. Using
this system, we first discovered the in vivo role of the 21kD GTPase Rac in protrusion and migration, then
showed that photoactivation of Rac in one cell could steer the entire cluster. For more than two decades
though, we were puzzled that expression of constitutively active Rac in border cells seemed to destroy the
entire egg chamber. During the current funding period, we solved this longstanding mystery. We discovered
that border cells expressing active Rac kill the nurse cells. Anterior follicle cells normally engulf and kill nurse
cells late in oogenesis, and we propose that active Rac prematurely activates this program. A similar
mechanism may explain otherwise mysterious immune deficiencies in human patients. Here we propose to
continue our exciting investigation of the spatiotemporal control of Rac-mediated cell migration and
engulfment in Drosophila. In Aim 1 we propose to elucidate the mechanisms of Rac-mediated cell killing.
Taking advantage of the border cell model, we will test the functional effects of each of the known activating
Rac mutations that cause immunodeficiencies in patients. We will test the hypothesis that border cells
expressing active Rac prematurely activate the normal developmental killing program, and we will define
more precisely the role of Rac within the molecular pathway. We will investigate how just six cells can
destroy an entire egg chamber, and we will identify the chemical, physical, and adhesive properties that
govern target cell selection. In Aim 2, we propose to follow up on our discovery that a basally localized Rac
activator is required for border cell cluster cohesion and migration. We will elucidate its relationship to
basolateral complex proteins and test whether its primary function is to localize Rac activity to basal
surfaces. We will test the hypothesis that basal Rac activity is required to generate basal protrusions that in
turn coordinate collective cell behavior. In Aim 3, we will follow up on a screen in which we have identified
Rho family activators and inhibitors required in border cells. We propose that border cells require elaborate
spatiotemporal control of Rac due to their needs to: maintain apicobasal polarity despite being detached
from basement membrane, extend and retract forward-directed protrusions, maintain cohesion under strain,
and inhibit inappropriate protrusion. Our ultimate goal is the decipher the Rac regulatory network.

Public health relevance
Relevance to public health Cell motility is a fundamental cell behavior that contributes to normal immune system function and is hijacked by cancer cells to spread, and we have developed a simple yet powerful animal model to study cell motility and engulfment (cells eating other cells). Our work has led to a novel understanding of a class of human immunodeficiencies and a novel strategy to improve cancer therapy. The current proposal is to uncover additional molecular mechanisms of cell motility and engulfment for the benefit of human health.